Molecular Mechanisms of APOBEC-Induced Mutagenesis in Cancer

PROJECT SUMMARY
Tumor heterogeneity is the main cause of resistance to current chemotherapy drugs as well as metastasis
development, leading to patients' death. Within the same tumor from the same patient, tumor cells might be
subtly or even dramatically different, making it harder to treat clinically. Understanding mechanisms driving
cancer diversity is a critical step toward developing new strategies to attenuate tumor evolution and adaptation.
Genomic instability is a prominent source of genetic diversity within tumors, generating a cell population
subject to potential selection from a micro-environmental or therapeutic context. In recent years, next-
generation sequencing technologies have begun to identify genomic signatures of DNA damage and errors in
DNA repair processes, revealing new mechanisms causing an accumulation of mutations in cancer genomes.
From the 30 mutational signatures identified across many cancer types to date, one is particularly dominant:
the APOBEC signature. APOBEC3A (A3A) and APOBEC3B (A3B), two members of the APOBEC3 family,
target TpC motifs on single-stranded DNA and are the major sources of the APOBEC mutational signature
detected in patients' tumor samples. Our preliminary observation identified a discrepancy between A3A and
A3B expression and mutation accumulation in cancer cells. On one hand, A3A is rarely found expressed, yet
many of the tumors have a strong A3A-mutational signature. On the other hand, A3B is expressed in most
cancer cells, but only a fraction has an A3B-mutational signature. Both A3A and A3B significantly increase
mutations in tumors, but these observations have led us to propose that A3A and A3B expression is not a
reliable way to assess the APOBEC status of cancer cells, as previously thought. We propose that A3A is
tightly regulated at the transcription level and transiently expressed to generate mutations. Our study will
explain why A3A is rarely found expressed in cancer but many cancers have a strong A3A mutational
signature. In contrast, we propose that A3B is regulated at the protein level to protect the genome against A3B
activity. Our goal is to uncover the molecular mechanisms that govern A3A and A3B regulation in cancer cells.
Our overall hypothesis is that cells exploit two separate mechanisms to regulate A3A and A3B and to protect
their genome against their activity. In addition, we propose that specific signals in cancer lead to the
deregulation of these protective mechanisms, causing a surge of mutations. Our Specific Aims are to 1)
define signaling pathways in cancer cells that regulate A3A expression and 2) identify protein complexes
controlling A3B activity in cancer cells. Our long-term goal is to develop therapeutic strategies to suppress
mutations in the genome caused by A3A and A3B, leading to tumor heterogeneity, metastasis, and drug
resistance.

Public health relevance
PROJECT NARRATIVE. A current challenge in cancer research is understanding tumor heterogeneity, a major cause of resistance to chemotherapy drugs as well as metastasis development. APOBEC3A and APOBEC3B have been identified as two of the major drivers of tumor heterogeneity by promoting the deamination of cytosine to uracil on DNA and inducing genomic mutations. The goal of this proposal is to uncover the molecular mechanisms that govern APOBEC3A and APOBEC3B regulation in cancer cells.